Pitt-Mozambique Training Program(Pitt-MozHRTP) in COVID-19, Cardiovascular Disease, and Diabetes in People with HIV

ABSTRACT
HIV infection continues to take a severe toll on Mozambique, which underscores the need for investments
in building research capacity to help combat the epidemic. To address this need, we propose to establish the
University of Pittsburgh (Pitt)-Mozambique HIV Research Training Program (Pitt-MozHRTP). The purpose of
the program is to build research capacity at two sister institutions of the Mozambique National Institute of
Health: the Polana Caniço Health Research Center (CISPOC) in Maputo, the capital city, and the Beira
Operations Research Center (CIOB), which is in the port city of Beira in central Mozambique. CISPOC and
CIOB both have growing HIV research portfolios and a commensurate need for increased research capacity.
The research focus of our program is COVID-19, cardiovascular disease, and diabetes in people with HIV
(CCD-PWH), all areas of enormous clinical and public health importance. Pitt-MozHRTP training sites will be at
Pitt and the University of Stellenbosch (SU) in Cape Town, South Africa. The program will be directed by Dr.
Lee Harrison at Pitt; Dr. Edna Viegas, who is responsible for overseeing research at CISPOC; and Dr. Jean
Nachega at SU. A broad array of degree (both PhD and master's) training opportunities will be available in
epidemiology and biostatistics, and laboratory sciences. In addition, we will offer post-doctoral fellowships for
exceptional candidates who have recently completed their doctoral training. We will also use workshops
conducted at CISPOC to augment research capacity at both CISPOC and CIOB. The program includes a
multidisciplinary group of experienced mentors and excellent training opportunities at each site. Each trainee
will have at least two mentors, one in Mozambique and another at the training site. The inclusion of SU
provides substantial opportunities for “south-to-south” training between Mozambique and neighboring South
Africa. In addition, the more experienced CISPOC will assist in building research capacity at CIOB. Trainees
will have access to all the substantial resources of the participating institutions. Over the five-year funding
period, we plan to train 6 masters students, 3 PhD students, and 5 post-doctoral fellows. In addition, ten
trainees will attend the Johns Hopkins Graduate Summer Institute of Epidemiology and Biostatistics and we
will conduct nine workshops at CISPOC. In summary, the Pitt-MozHRTP will make major contributions to
building research capacity in the area CCD-PWH in Mozambique by providing a broad array of exceptional
training opportunities.

Public health relevance
Project Narrative We propose to establish the University of Pittsburg-Mozambique HIV Research Training Program (Pitt- MozHRTP), which has as its primary goal the enhancement of research capacity in the areas of COVID-19, cardiovascular diseases, and diabetes in people with HIV. This will be accomplished by an expert, multidisciplinary team of research mentors and excellent training opportunities at the University of Pittsburgh, Pittsburgh, USA and the University of Stellenbosch, Cape Town, South Africa. By the end of the five-year funding period, we anticipate that we will have made a huge impact on HIV research capacity in Mozambique.